Telemedicine for Treatment of Opioid Use Disorder

PROJECT SUMMARY: A key challenge in combating the opioid epidemic has been connecting individuals
with opioid use disorder to evidence-based treatments. The President's Commission on Combating Drug
Addiction and the Opioid Crisis and others have suggested that telemedicine for substance use disorder (“tele-
SUD”) may be part of the solution. In preliminary analyses, we have found that tele-SUD use is growing
rapidly, and there is widespread policy interest in Congress and state legislatures in how to accelerate this
growth. The SUPPORT for Patients and Communities Act, signed into law in October 2018, includes several
provisions intended to reduce barriers to tele-SUD use and will likely increase the availability of and
reimbursement for tele-SUD. However, despite the widespread interest and growing use, there has never been
a rigorous assessment of tele-SUD. For example, what are the different tele-SUD models being used to treat
opioid use disorder, what barriers exist to greater use of tele-SUD, and is tele-SUD use associated with
improved (or potentially worse) quality of care for people with opioid use disorder? To fill this knowledge gap,
we propose a comprehensive national evaluation of telemedicine for opioid use disorder using data through
2021 from Medicaid, Medicare, and commercial insurance as well as a series of qualitative interviews. Our
Aims are to: (1) describe the different models of how tele-SUD is being incorporated into opioid use disorder
care and how this is changing over time, (2) identify regional factors associated with greater tele-SUD use for
opioid use disorder, (3) examine the association between tele-SUD use and quality of opioid use disorder care
received and whether this varies by model, and (4) describe existing tele-SUD programs, and identify barriers
and facilitators to tele-SUD adoption and sustainability.
The proposed mixed-methods study will help providers interested in using tele-SUD and inform ongoing
debates about regulations and reimbursement for tele-SUD in Congress and state legislatures. Our goal is to
highlight policies and practices that drive greater use of tele-SUD and explore its potential role in improving
access to, and quality of, care for individuals with opioid use disorder. Our research will help inform how tele-
SUD may be leveraged to combat the opioid epidemic as well as other substance use disorders, such as
alcohol and methamphetamine use disorders.

Public health relevance
PROJECT NARRATIVE: Many patients with opioid use disorder have great difficulty accessing substance use disorder (SUD) treatment. Telemedicine for SUD (“tele-SUD”) is one potential solution, and many states and the Congress are considering laws and regulations to encourage greater tele-SUD use. In this project, our goal is to understand how tele-SUD is being used for patients, what drives the variation in use, whether tele-SUD is associated with better care, and how some providers have successfully used tele-SUD.